Language Identity and Mental Health Disparities among Multilingual 1.5 Generation Asian/Asian American Immigrant Young Adults: A Mixed Methods Study

PROJECT SUMMARY
Asian American immigrants have been particularly vulnerable to health disparities and mental health conditions
during the COVID-19 pandemic in comparison to other racial/ethnic groups. There are multiple reasons: a
language barrier, its impacts on isolation and marginalization, and anti-Asian hate crime and incidents. In the
proposal, we will focus on the detailed component of a language barrier (language proficiency and language
identity), and its effect on mental health disparities. Most of the Asian/Asian American immigrants begin using
English as an additional language (L2) once they arrive in the U.S., after mainly using a first language (L1) from
their parent's country of origin. 1.5 generation Asian/Asian American immigrant young adults—those who
migrated to the U.S. with their parents (1st generation) from Asian countries when they were children aged
between 5 and 17, have been living in the U.S. at least 2 years, and current ages are between 18 and 25—are a
significant health disparity population. However, little research to date has examined how learning an L2 among
1.5 generation Asian/Asian American immigrant young adults informs their sense of acceptance, inclusion, and
identity as well as their acculturation, socialization, and psychological well-being in American society. To close
this research gap, the objective of the proposed work is to investigate the association between learning an L2 and
mental health disparities among 1.5 generation young adults from Asian ethnic groups/Asian Americans as
health disparity populations. The central hypothesis of this study is that for socioeconomically diverse 1.5
generation Asian/Asian American immigrant young adults, those who grew up affiliating with one culture and
now may also need to affiliate with a new dominant American culture, are more likely to experience psychosocial
adversity and mental health disparities. This project has two specific aims, using a mixed-methods research
design. First, using quantitative analysis, we will determine the extent to which perceived language
proficiency/language identity in 1.5 generation Asian/Asian American young adults is associated with
psychological well-being and mental health (Aim 1). Second, using qualitative analysis, we will gain an in-depth
understanding of experiences with acculturation and discrimination and how these experiences relate to their
perceptions of language skills and psychological well-being/mental health disparities (Aim 2). Data from the
study will be the foundation for the development of Asian immigrant-tailored psychological health strategies for
successful acculturation in American society associated with learning an L2 that has not been substantially
discussed. The project carries practical implications for promoting the design and implementation of multi-
sectoral interventions to address the structural drivers of health disparities (e.g., racism and discrimination). In
addition, it will bring attention to establishing the culturally congruent multilingual competence for the
development of 1.5 generation Asian/Asian American immigrant populations' strong sense of acceptance,
inclusion, and identity in American society to achieve the goal of health equity for all in the U.S.

Public health relevance
PROJECT NARRATIVE: PUBLIC HEALTH RELEVANCE STATEMENT Asian/Asian American immigrant young adults learn multiple languages, being exposed to English as an additional language (L2) in the U.S. after mainly using a first language (L1) from their country of origin. In this grant, we propose to investigate the impact of learning an additional language, namely, the dominant language of the community, on Asian/Asian American immigrant young adults' mental health and psychological well-being as well as their sense of acceptance, inclusion, and ethnic identity in the U.S. Our study will provide suggestions to address the structural drivers of mental health disparities among immigrant populations, such as results of the experience of racism and discrimination, which are linked to individual's own multilingual language identity and skills.